High-throughput analysis of dynamics of antibody responses against defined epitopes: prioritization of diagnostic and prognostic markers for Chagas disease

1 PROJECT SUMMARY / ABSTRACT
2
3 Trypanosoma cruzi is a parasite responsible for an important human disease, Chagas Disease, which
4 is endemic in the Americas. The parasite is transmitted by the bite of an insect, or by blood transfusion
5 or organ transplants. Current treatment is limited to two nitro-heterocyclic drugs, which can cure the
6 disease in its acute phase, and provide benefits to patients in the chronic stage, but they have
7 unwanted adverse effects. New drugs and treatments are being explored, but certification of cure in
8 clinical trials is difficult to achieve. Management of this disease rests heavily on the use of diagnostic
9 tools: either molecular detection of parasite DNA by PCR or circulating antibodies against parasite
10 proteins or protein fragments. Detection of parasite DNA is difficult in the chronic stage of the disease
11 where parasitemia is low or undetectable, and hence requires serial blood sampling and PCR
12 replicates to achieve reliable detection. In contrast, serological assays readily detect infections, and
13 reduction in antibody levels (seroconversion or trend to seroconversion) have been historically used
14 as primary endpoints in clinical trials with some success but requiring long follow-ups of patients. A
15 major unmet need in this area is thus the ability to produce earlier informative outcomes for treatment
16 success or failure. This constitutes a major obstacle in current drug trials. For this, a constant stream
17 of new biomarkers is required to explore their potential at these tasks. One of the most promising
18 developments in the field was the construction of an Atlas of Antigens and Epitopes for Chagas
19 disease, providing extensive information on the seroprevalence of defined epitopes across diverse
20 populations of infected patients. Using a large set of antigens identified in this Atlas, we are beginning
21 to obtain valuable information on how individual antibody repertoires of patients in a clinical trial
22 respond to treatments. In this application we build on this previous work and propose to characterize
23 the dynamics of the human antibody response against this parasite. Using peptide microarrays
24 displaying selected Trypanosoma cruzi peptide antigens we will investigate these dynamics in an
25 expanded set of retrospective samples from diverse patient populations. We will use this information
26 to prioritize serology markers for applications seeking to monitor disease status or progression. With
27 this set of prioritized antigens, we will produce proof-of-principle immunoassays for use in clinical
28 settings.

Public health relevance
PROJECT NARRATIVE Chagas disease is an endemic infectious disease across the Americas that can be fatal in children and progresses into a debilitating chronic stage in adults. Using state-of-the-art technology, we are studying the dynamics of human antibody immune responses against the parasite to identify much needed biomarkers for key diagnostic applications. A comprehensive set of new biomarkers and immunoassays will lead to improved tools to guide control and monitor efficacy of therapeutic treatments.